IMMUNOLOGICAL INVESTIGATION OF ROOT SURFACE CARIES

Determine whether the concentrations of local immunoglobulins of any major isotype are correlated with root surface caries. Determine whether caries of root surfaces is correlated with isotype-specific antibody titers to any bacteria in a panel of six species. Determine whether local specific antibody levels are suggestive of protective immunity in root surface caries.